NRSA Training Core

The TL1 program at the New York University (NYU) – Health and Hospitals (H+H) CTSI provides innovative,
university-wide, transdisciplinary training of the next generation of scientists conducting clinical and translational
research (CTR). Our trainees arrive at an advanced stage of training, with established areas of inquiry and
capable primary research mentors, but require further mentoring and experience. Our guiding premise is to
change their worldview from one of personal scientific success, to a broader and more creative mindset where
they interact continually and span disciplinary boundaries to advance knowledge and health. Our program is
unique in both the wide scope of disciplines represented and in being the only T-supported program at our hub
to include trainees from clinical, basic, and non-STEM backgrounds. Trainees work across the lifespan and with
diverse populations to develop new approaches to improve health, and collaborate to develop transdisciplinary
and team-building skills and a broader translational vision. To support the emergence of clinical and translational
scientists, our TL1 program provides full-time pre- and post-doctoral research training focusing on trainees
interested in careers in CTR. Our three specific aims are to: 1) develop trainees with the collaborative skills
needed to lead multidisciplinary CTR teams; 2) enhance trainees’ communicative effectiveness across the CTR
spectrum; and 3) accelerate trainee career progression into independent CTR positions. Beyond supporting each
trainee’s methodologic skills and discipline-specific advancement, we focus on trainee development to provide
the skills most often cited as underdeveloped in multi-disciplinary, team-based science. To extend beyond
research training in specific disciplines, we promote the “Three Cs”—Collaboration, Communication, and
Career Development. The foundational project that transforms this aspirational philosophy into actual
behavioral change is our every-other-week Student-to-Scholar (STS) seminar—a forum where trainees meet,
reflect, learn, bond, and teach one another. Each session addresses an aspect of the three Cs. Trainees conduct
their own discipline-specific research with their research mentor and take additional courses related to the three
Cs (e.g., manuscript writing, team science, responsible conduct of research, career planning, grant writing), and
one elective course (e.g., health policy, drug development). Trainees also participate in the annual Association
of Clinical and Translational Science meeting, our CTSI’s fortnightly Translational Research in Progress (TRIP)
seminar, our monthly TREC Grand Rounds in Career Development, and an annual T and K research
symposium/networking meeting, hosted by NYU and including all CTSAs in the NYC area. We emphasize faculty
recognition of and response to the unique needs of each trainee, while maintaining a cohort model to provide
support, encouragement, and accountability. In the next funding period, our augmented mentor-training program
will emphasize co-mentoring so each trainee gets optimal personalized development as a translational scientist.